Promoting HIV health behaviors among pregnant couples in Zambia using an adaptive relationship strengthening intervention

PROJECT SUMMARY/ABSTRACT
Candidate: I am a behavioral health researcher with expertise in the social determinants of HIV, with a particular
emphasis on prevention of mother-to-child transmission (PMTCT) in sub-Saharan Africa. My long-term career
goal is to be a tenure-track professor in a school of public health with a robust research portfolio focused on
family-based HIV prevention and treatment strategies. My prior training and experiences have enabled me to
conduct rigorous research on the social and behavioral aspects of HIV in various global settings. However, to
become a top investigator in my field capable of securing R01 funding, I require additional training and
mentorship in intervention design and evaluation. The K99/R00 Pathway to Independence Award is a logical
progression from my previous research and training. Under the mentorship of an exceptional team of
researchers, I will focus my training phase of the award on career development activities that facilitate my
transition to an independent behavioral HIV investigator capable of leading intervention trials in resource limited
settings. Mentored Phase Research (K99, years 1-2): The effectiveness of PMTCT programs is dependent on
optimizing pregnant and postpartum women’s adherence to antiretroviral therapy (ART) and sustained
engagement in care. In high HIV prevalence settings of sub-Saharan Africa, such as Zambia, women are lost-
to-follow up at alarming rates across the cascade of care. Contextual factors, such as relationship dynamics with
male partners (relationship satisfaction, communication, conflict resolution), are a long-overlooked influence in
women’s PMTCT-related health behaviors. Couples counseling interventions in the region have proven
successful in strengthening relationships and promoting some HIV prevention behaviors, such couples HIV
testing. In order to test if a couples counseling approach can extend to PMTCT outcomes in Zambia, I will
refine a couples counseling intervention for HIV-positive pregnant women and their male partners (Aim 1). The
intervention is based on elements of my mentors’ successful couples counseling models and uses a unique
adaptive design. I will refine the content and delivery of the proposed intervention through qualitative interviews
and focus groups with HIV-positive pregnant women, their male partners, and service providers, while engaging
stakeholders and building my research capacity in this setting. Independent Phase Research (R00, Years 3-
5): I will implement a single-site randomized controlled trial of the couples counseling intervention (n=238
couples; 119 per arm) and assess service utilization and PMTCT outcome indicators, including women’s viral
load at 9 months postpartum, self-reported ART adherence, and retention in PMTCT care (Aim 2). I will also
establish the effect of the intervention on intra- and inter-personal mechanisms I hypothesize to be on the causal
pathway influencing PMTCT outcomes (Aim 3) through behavioral surveys at baseline, 3 and 9 months
postpartum. Future Directions: Findings from this study will provide evidence of the preliminary efficacy of the
couples counseling intervention to promote PMTCT adherence and retention, which will be used to develop a
larger multi-site R01 trial with longer-term HIV outcomes.

Public health relevance
PROJECT NARRATIVE Prevention of mother-to-child transmission (PMTCT) programs are a unique opportunity to make substantial gains towards ending the global AIDS epidemic, but require sustained adherence and retention of mother-baby pairs. I propose to develop and test a couples counseling intervention focused on relationship dynamics for HIV- positive pregnant women and their male partners in Zambia to promote service utilization and PMTCT outcomes, and ascertain underlying mechanisms. The intervention has the potential to significantly reduce the burden of disease among families affected by HIV.